Sex- and Age-dependent ACL Function in the Growing Knee Joint

ABSTRACT
Recent data indicates that the fastest rising rates of anterior cruciate ligament (ACL) injuries of the knee are
reported in children and adolescents with significant growth remaining. In the skeletally immature patient
population, surgical reconstruction is increasingly suggested for complete ACL tears. However, the choice of
non-surgical treatment or immediate surgical reconstruction of ACL tears remains a subject of debate in young
patients with significant growth remaining or in the case of partial tears involving one ACL bundle. Sex appears
to be a major risk factor for ACL injury during adolescence, but not in childhood, adding another layer of
complexity. For both complete and partial ACL injuries, treatment algorithms have been developed without
considering the potential sex- and age-dependent function of the ACL, due to the paucity of available data.
Thus, the objective of this proposal is to determine how age and sex impact ACL maturation and joint function
during skeletal growth and to assess if this knowledge can be applied to improve treatment after ACL injury.
Aim 1 will determine how sex impacts the maturation of the ACL as well as that of its individual AM and PL
bundles during skeletal growth. Aim 2 will determine how age and sex impact the immediate loading of
secondary tissues in-vitro and the remodeling response of the joint in-vivo following loss of function of the AM
bundle, PL bundle, or the entire ACL. Aim 3 will determine how replacement graft type and placement should
vary to restore age- and sex-specific ACL and joint function. Successful completion of these aims will provide a
basic science foundation for the development of age- and sex-specific algorithms for the treatment of ACL
injuries.
!

Public health relevance
RELEVANCE TO PUBLIC HEALTH With increasing activity and participation in organized sports within children and adolescents, injuries to the anterior cruciate ligament (ACL) of the knee joint are rising dramatically, and appropriate age- and sex- dependent treatment algorithms are still unclear. The goal of this proposal is to determine how age and sex impact ACL maturation and joint function during skeletal growth and to assess if this knowledge can be applied to improve treatment after ACL injury. Such information will be critical to guide sex- and age-specific treatment strategies for children or adolescents with ACL injuries and significant remaining growth, and the knowledge obtained can be extended to guide new surgical and/or non-operative treatment.